Experience-dependent tuning of socially selective neural circuits

PROJECT SUMMARY
Appropriately recognizing and responding to social partners is a fundamental principle guiding every social
interaction from single cells to humans. Social environment is known to interact with development to give rise
to typical behavioral responses, however the mechanisms by which social experience shapes the development
and tuning features of the nervous system to give rise to these behaviors remains poorly understood. How
does the social environment throughout development interact to shape how the brain encodes and
discriminates social information? The proposed research addresses these questions in a novel experimentally
tractable system for investigating social development of a neural circuit, the northern paper wasp, Polistes
fuscatus. P. fuscatus females have highly diverse color markings on their face which they use to discriminate
social partners via vision alone. Like humans, P. fuscatus wasps treat faces as special visual objects and the
development of this specialized recognition ability is dependent on social experience. The social lives of these
wasps are rich and complex, allowing for highly refined social memory and even transitive inference of social
relationships. Conveniently, wasps do not possess image forming eyes prior to adult emergence. This key
feature allows for the ability to precisely control both the timing and diversity of social experience, while
maintaining normal larval development. Further, we have recently discovered a common population of socially
responsive neurons in the central brain of P. fuscatus, which show selective tuning to visual stimuli of forward-
facing wasps above other visual objects, analogous to the ‘face cells’ in the primate brain. These cells encode
both social detection and identity discrimination, providing a clear neural target to study how social experience
shapes the tuning features of a socially selective circuits. The proposed experiments take advantage of the
unique strengths of this system to address this question at three levels. First, we will assess how these circuits
are impacted by long-term social isolation. Second, we will track the developmental tuning trajectory of these
circuits to identify how these circuits develop and are refined through maturity to give rise to the highly
selective features found in mature adult wasps. Third, we will investigate how both individual neural and
population-level tuning features are affected by the diversity of social experiences wasps have, via
manipulation of facial diversity among groups. These experiments will aid in discovering fundamental features
of how social circuits are tuned via social experience and guide future experiments to identify shared principles
guiding social cognition. Further this award will also support the awardee’s transition to an independent
research career at a research-intensive university and support the establishment of their laboratory studying
how social experience shapes the development of circuits underlying social cognition.

Public health relevance
PROJECT NARATIVE Recognizing and responding to social cues is fundamental for health and wellbeing, though the developmental processes by which neural circuits supporting recognition are shaped is poorly understood. The proposed research leverages an invertebrate model of individual facial recognition, a paper wasp that also requires social experience for normal development of recognition. The ability to easily manipulate social experience coupled with the smaller brain and rapid development time of paper wasps will aid in discovering basic principles by which social experience modulates neural circuits.